Molecular determinants of synaptic diversity at the nanoscale

-Abstract -
Synapses are the fundamental units of communication in the nervous system and reliable synaptic
transmission is central to key nervous system processes such as learning, memory, and sensory adaptation.
Moreover, due to dysfunctions at the synapse, many neurological diseases may develop. While
electrophysiological studies of synaptic transmission have been around for a long time, only the recent
development of optical quantal analysis (OQA) tools has made possible to correlate morphological and structural
elements to transmission properties of individual synapses. Studies using OQA have revealed a much larger
diversity in synaptic transmission, even among neighboring synapses, than was previously thought. The advent
of higher-resolution OQA, such as the one developed in our lab called “QuaSOR”, and super-resolution structural
imaging methods opens up an exciting frontier of being able to investigate how neural activity shapes (and is
shaped by) synaptic diversity, what are the molecular determinants and mechanisms the set this diversity, and
how do these molecular determinants shape synaptic diversity.
By using OQA, we've shown that synaptic diversity, as measured by difference in synaptic strength (i.e.,
probability of action potential evoked transmission; Pr ) is extremely heterogeneous (Pr: 0.01–0.5) within a single
neuron synapsing onto a single target cell. This high degree of heterogeneity leads us to the central hypothesis
of my thesis which is that synaptic strength is set by a very precise, local distribution of key proteins. To test this
hypothesis I will use the model glutamatergic synapse–Drosophila melanogaster larval neuromuscular junction
(NMJ)– where I will investigate hundreds of synapses in parallel, in vivo, and address synaptic heterogeneity
from both functional and structural perspectives at single synapse resolution (50-100nm). For my thesis I am
being trained in synaptic physiology, fly genetics, and advanced super-resolution functional/structural imaging
and analysis. In Aim 1 of my thesis, I will establish the degree of functional synaptic heterogeneity in vivo single
synapses using QuaSOR. Specifically, I have completed the preliminary experiments investigating the extent of
basal synaptic heterogeneity and addressing the relationship between basal strength of synapses (basal Pr) and
synaptic adaptation to higher frequencies. Through super-resolution structural imaging experiments proposed
for Aim 2, I will investigate some of the key proteins at the synapse and determine whether it's the local quantities,
the relative abundance between them (ratios), and/or the nanolocalization within the synapse that shape synaptic
diversity. Finally, for Aim 3, through chronic and acute manipulations, I will determine the role of Unc-13a in
shaping this diversity. Through the combination of super resolution structural and functional imaging, this
proposed work will yield much needed insight into the molecular determinants that may shape synaptic diversity.

Public health relevance
-Project Narrative- Synapses are the fundamental units of communication between neurons and reliable synaptic transmission is essential to key nervous system functions such as learning, memory, and sensory adaptations. Understanding the underlying mechanisms of synaptic transmission is a significant goal of neuroscience and human health research in general since dysfunctions at the synapse may lead to many neurodegenerative (such as Parkinson's Disease) and neurodevelopmental (such as Autism Spectrum Disorder and Schizophrenia) disorders. Knowledge of the molecular mechanisms that shape synaptic transmission will aid in the development of novel pharmacological targets and therapeutic approaches for treating neurodevelopmental and neurodegenerative disorders.